University of Washington GI Training Grant

PROJECT SUMMARY/ABSTRACT
The University of Washington School of Medicine serves as the sole medical educational resource for 5 states
in the US Northwest: Washington, Wyoming, Alaska, Montana, and Idaho. It is also recognized as a major
institution in biomedical research; since 1974, UW ranks first amongst American public universities for federal
research funding and in the top three amongst all universities (public and private) since 1991 for competing
federal science and engineering grants. Within the UW, the Division of Gastroenterology of the Department of
Medicine, composed of a core of 45 full-time faculty members, operates from five medical centers: the University
of Washington Health Sciences Center, the Veterans Affairs Puget Sound Health Care System, the Harborview
Medical Center, Northwest Hospital and the Seattle Cancer Care Alliance/Fred Hutchinson Cancer Research
Center.
In this renewal application for the UW GI Training Grant, we have developed a formal collaboration with
Seattle Children’s Hospital to increase the pool of talented candidates, enhance the resources available to
trainees, and to expand discovery across the lifetime of patients with gastrointestinal and liver disease. Our
diversity allows the research and clinical programs of the GI Division to benefit from complementary strengths,
ranging from pediatric to adult patients, from tertiary referral centers to primary care centers in urban or rural
settings, and from highly specialized centers to broadly diversified county medical centers.
Benefiting from these strengths, the UW GI Division has had a long tradition of training academic fellows,
dating to the 1950’s, and the UW GI Training Grant has funded 40 fellows over the past two decades, of whom
30 have successfully achieved and currently thrive in research-focused careers. This application requests two
trainees per year who will undergo rigorous research training for two years (4 positions total).

Public health relevance
PROJECT NARRATIVE This grant application proposes to integrate training in basic/translational science with clinical research to develop the next generation of scientists who will embark upon discovery to improve the health of individuals and of populations. Trainees in our program will be exposed to a wealth of resources, use cutting-edge technology and be mentored by highly successful preceptors in a supportive environment dedicated to developing the foundation for their careers in academic medicine.